GENETIC EPIDEMIOLOGY FOR DYSLIPIDEMIA AND CORONARY ARTERY DISEASE

The CDMAS ssytem is used to prepare data sets for analysis on another cluster of workstations where genetic analysis of dyslipidemia is done.